Social and policy determinants and impacts on COVID-19 and influenza disparities

PROJECT SUMMARY
The purpose of this K01 proposal is to provide Alina Schnake-Mahl, ScD MPH with the protected time and
resources to pursue the additional training needed to reach her long-term goal of an independent academic
career in health policy and social epidemiology, focused on generating evidence to inform law and policies that
reduce health inequities in infectious diseases. This proposal builds on Dr. Schnake-Mahl’s background as a
social epidemiologist with expertise in health policy. It also leverages her experience with applied health care
research and evaluation, and a cohesive mentorship team, to improve our understanding of the social
determinants of COVID-19 and influenza disparities. Over 878,000 people have been hospitalized for COVID-
19 over the last year, and between 140,000 to 710,000 people are hospitalized for flu annually. Studies have
found wide disparities in COVID-19 and influenza, but gaps remain with respect to the interactions between the
social determinants of these disparities. This project uses diverse and multi-disciplinary approaches to
examine the determinants of disparities and effects of policy exposures on disparities. The specific aims are to:
1) use multilevel analysis to describe the social determinants of racial and geographic disparities in influenza
and COVID-19 outcomes in US cities; 2) use non-experimental causal inference methods to estimate the effect
of PSL and rent control laws on rates and disparities of influenza and COVID-19 outcomes in US cities; 3) use
agent based modeling to understand mechanisms linking two key social determinants, occupational exposures
and housing overcrowding, and influenza disparities. The training goals are designed to expand skills and
knowledge through training in infectious disease epidemiology, casual inference methods for policy analysis,
and systems approaches including agent-based modeling. Training in this set of complementary approaches
will position the candidate to pursue innovative research in the area of infectious disease disparities as part of
a future R01. The proposed work has substantial potential to make a significant public health impact as these
aims will advance our understanding of the social determinants of COVID-19 and influenza disparities and
provide a strong evidence-base for policies and interventions that may address these inequities and reduce the
overall burden of COVID-19 and influenza. Furthermore, this K01 develops specific topic area (infectious
disease) and methods (advanced causal inference for policy analysis and systems dynamics) expertise whose
extension to other infectious disease indicates applicability beyond the scope of this proposal. The proposed
work is feasible and realistic within the award period and will allow Dr. Schnake-Mahl to continue to build
research skills, extend professional networks, generate numerous publications, and compete for other NIH
funding. In summary, this K01 award will support and stimulate the career development activities of Dr.
Schnake Mahl and allow her to successfully move into the next phase of her career as an independent
investigator.

Public health relevance
PROJECT NARRATIVE COVID-19 and influenza account for a substantial disease burden in the United States, and both show substantial disparities. The proposed research uses descriptive, non-experimental, and agent based-modeling to examine 1) neighborhood social determinants of COVID-19 and influenza acute care utilization (hospitalizations and Emergency Department visits) under varying contexts, 2) effects of two policies (paid sick leave and rent control) on these outcomes, and 3) develops hypothesis about the mechanisms linking two key social determinants, occupational exposures and housing overcrowding, and influenza disparities. Findings will advance our understanding of the social and policy drivers of infectious disease disparities and inform policies and interventions that can mitigate disparities in seasonal, endemic, and other potential future respiratory illness pandemics.